Molecular mechanisms of enterovirus D68 viral entry mediated by the MFSD6 receptor

PROJECT SUMMARY
Nonpolio enteroviruses are ubiquitous viruses that generally cause mild respiratory and gastrointestinal
symptoms but can, in rare cases, cause severe disease. Recent outbreaks of enterovirus D68 (EV-D68) have
been associated with severe respiratory disease requiring hospitalization and neuropathogenesis, including
polio-like paralysis syndrome. Despite the clinical relevance of EV-D68, there are no antiviral agents or licensed
vaccines available, and EV-D68’s interactions with host proteins remains largely uncharacterized. In preliminary
data, we have used genome-scale CRISPR screens and identified the poorly characterized multipass membrane
transporter MFSD6 as a host entry factor for EV-D68. Knockout of MFSD6 expression abrogated EV-D68
infection of human cell lines derived from the lungs and the CNS. We show that MFSD6 is localized at the plasma
membrane, and is required for viral internalization into the host cell. MFSD6 directly binds to EV-D68 particles
via its third extracellular loop (L3). A decoy receptor, engineered by fusing MFSD6(L3) to Fc, blocked EV-D68
infection of human primary lung epithelial cells, and provided near complete protection against pathogenesis in
a lethal mouse model of EV-D68 CNS infection. The preliminary data point to an essential role of MFSD6 as
entry receptor, and its broad expression pattern in multiple tissues, including the spinal cord and lungs, suggest
a role in pathogenesis. We hypothesize that the binding of EV-D68 with MFSD6 via molecular interactions results
in the functional entry of EV-D68 RNA into the cell, and that this interaction is important for disease pathogenesis.
The primary goals of this collaborative proposal between the Carette, Chiu, and Nagamine laboratories are: (1)
to define the precise mechanism(s) by which MFSD6 facilitates EV-D68 entry into cells, (2) to gain high-resolution
structural insight as to how MFSD6 engages the EV-D68 virion, and (3) to determine the detailed role of MFSD6
in the pathogenesis of EV-D68 infection in vivo using murine models. Our results will provide detailed insights
into receptor-virus interactions and the fundamental entry mechanism of an emerging neurotropic picornavirus
with pandemic potential. This information may facilitate the development of small molecules or biologicals that
disrupt MFSD6 interaction with EV-D68, which could form the basis of future therapeutics that ameliorate
disease.

Public health relevance
PROJECT NARRATIVE Nonpolio enteroviruses are ubiquitous pathogens generally causing self-limiting mild upper respiratory symptoms in children. However, recent enterovirus D68 outbreaks have been associated with severe clinical manifestations including respiratory disease requiring hospitalization and the paralysis syndrome acute flaccid myelitis. Our contributions will illuminate cellular targets critical for infection and host responses, which will inform strategies for mitigating EV-D68 infection and neuropathogenesis.